Beneficial Effects of FPR Agonists on an Animal Model of Early Stage Heart Failure with Preserved Ejection Fraction

Heart failure (HF) is the most common cause of Medicare hospitalizations. About 50% of HF patients suffer from
HF with low ejection fraction (HFrEF) for which there are treatments. The other 50% suffer from HFpEF,
(preserved ejection fraction) characterized by the inability of the left ventricle (LV) to accommodate larger filling
volumes upon greater demands in cardiac output. Currently, no treatments are available for HFpEF and studies
demonstrate a female predominance (2:1 vs. men). Noteworthy, the VA has identified as a research priority
Women Veteran’s health. HFpEF pathophysiology is complex and the cause for female predominance is unclear.
However, studies strongly suggest a role for LV fibrosis in the development of HFpEF which, appears
accentuated in post-menopausal women. Thus, there is a need to identify, evaluate and develop novel
treatments in pre- or later stage HFpEF female animal models targeting fibrosis leading to improved LV function.
Cardiac fibrosis is preceded and orchestrated by dysregulated inflammation where macrophages are key.
Systemic inflammation derived from the presence of kidney disease, obesity, type 2 diabetes and/or
hypertension leading to the activation of pro-inflammatory cytokines was identified as a likely key contributor to
HFpEF. Pharmacologic approaches that non-specifically inhibit inflammation so as to attenuate fibrosis, are
poorly tolerated. However, selective and targeted modulation of inflammation has emerged as a concept
whereby the dysregulated process may be physiologically controlled leading to reduced fibrosis. The discovery
of pro-resolution mediators such as lipoxins and resolvins as well as the identification of their receptors such as
the formyl peptide receptor (FPR), has led to new insights towards addressing unresolved inflammation.
Macrophages express FPR that when stimulated, induce their M2 like polarization to a pro-resolution phenotype.
We utilized FPR agonists in rodent models of myocardial infarction where treatment significantly improves LV
function and reduces non-infarcted area fibrosis. However, no studies have assessed their potential use in pre-
clinical female models of HFpEF. We propose that: “Treatment with FPR agonists polarizes macrophages to a
pro-resolution phenotype limiting adverse left ventricular remodeling and fibrosis in animal models mimicking
HFpEF in women, leading to improved chamber function”. Aim 1 will test if the oral administration of an FPR
agonist (compound 43) to a female animal model of early stage HFpEF prevents the development of fibrosis
leading to the preservation of optimal myocardial material properties and thus, improved left ventricular diastolic
and systolic function. Aim 2 if the oral administration of an FPR agonist to a female animal model of HFpEF
compounded by renal injury ameliorates tissue fibrosis leading to the preservation of optimal myocardial material
properties and thus, improved left ventricular diastolic and systolic function. Aim 3 if the oral administration of an
FPR agonist to female animal models of early stage or compounded HFpEF normalizes blood levels of pro-
inflammatory cytokines and triggers the polarization of macrophages to a pro-resolution phenotype. We will also
perform a broader characterization of the infiltrating leucocyte population as well as macrophage derived
conditioned media treatment of culture cardiac fibroblasts to assess its effects on cell phenotype.

Public health relevance
Heart diseases and in particular, heart failure are an increasing serious health concern in the Veteran population in particular, as the population ages and are exposed to risk factors such as post-traumatic stress disorder. Heart failure with preserved ejection fraction is more commonly seen in women and the VA has identified Women’s Veterans health as an area of priority research. Nearly 70% of male veterans are older than 55 years of age and the majority of female veterans are over 45 years of age (National Center for Veterans Analysis and Statistics report 2011). The current proposal aims to address the role of uncontrolled inflammation in the development of cardiac fibrosis in female animal models of heart failure with preserved ejection fraction where the heart fails to accommodate greater blood pumping volumes. The work described in this proposal will also test novel therapeutic strategies that may be effective in the future treatment of this disease.